ACQUISITION OF MORPHOLOGICAL PROCESSES IN ASL

The general objective of our research is to study the human capacitu for language. We aim to investigate to what extent the overall form and organization of language is determined by the articulatory and perceptual modality in which it has developed, and to what extent these represent more fundamental aspects of human cognition. As a research tool we study American Sign Language (ASL), the system of hand signs developed by deaf people in the absence of speech. We find that ASL differs dramatically from English and other spoken languages in some of the mechanisms by which its lexical units are modified. For the form of its inflectional and derivational processes the mode in which the language develops makes a crucial difference. In this grant we propose to study the acquisition of three contrasting subsystems of American Sign Language: 1) The system of morphological processes which operate on signs, simultaneously changing or adding specifications for dimensions of movement to the root form of the sign. 2) Compounding processes which are essentially sequential combinations of signs, bound together by particular rhythmic properties which differentiate them from phrases. 3) Spatial indexing, a system which includes the establishment of loci for non-present referents in the signing space between signer and addressee, and anaphoric reference by pointing or by inflection of verb. Detailed longitudinal studies of spontaneous mother/child interactions on videotape are augmented with experimental interventions. We have chosen to investigate the acquisition of specific aspects of the grammar, selected so that some are most like and some are most unlike comparable processes in spoken language. In the process, we investigate the acquisition of some of the most distinctive aspects of signed languages: its conflation, its simultaneity and its structured use of space. The comparison of the acquisition of signed and spoken languages becomes a priviledged ground for testing hypotheses about the mechanisms that determine language structure.